Defining the role of single-cell heterogeneity in bacterial vaginosis

PROJECT SUMMARY/ABSTRACT
A major challenge in bacterial pathogenesis is the prevention and treatment of polymicrobial diseases, as
microbe-microbe interactions alter the initiation of disease and its susceptibility to antimicrobial treatment. For
example, bacterial vaginosis (BV) occurs within the vaginal microbial community, and the factors that drive its
initiation, treatment, and high levels of recurrence (>50%) are not understood. BV is the most common condition
of the female genital tract in reproductive-aged women, impacting over 29% of women in the United States with
an estimated annual economic burden of $5 billion in North America. Importantly, in addition to vaginal pain,
odor, and discharge, BV causes increased susceptibility to sexually transmitted infections, including HIV, and is
associated with preterm birth and cervical cancer. Research has sought to understand BV pathogenesis through
studying differences in community composition at the species, genus, and phylum levels and through identifying
genomic and phenotypic differences across BV microbes. However, this previous work only partially explains
differences across women in the development of BV and the response to treatment. This proposal investigates
single-cell genomic and transcriptomic diversity as two underexplored areas that will transform our understanding
of the underlying factors that control BV progression. The goal of this proposal is to identify aspects of diversity
that impact BV and provide insights into new strategies for prevention, treatment, and diagnosis. Further, these
findings will have broad applicability to polymicrobial infections. In this study, the overarching hypothesis is that
intrapersonal strain-level genomic diversity and transcriptomic heterogeneity alter the stability of communities,
their interactions with the host, and their susceptibility to treatment. First, this proposal tests the importance of
intrapersonal strain-level diversity in pre-clinical models and clinical specimens (Objective 1). Across microbiome
sites and polymicrobial infections, including in the vaginal microbiome, previous work has identified that
individuals can concurrently harbor multiple strains of the same species, but the functional implications of this
diversity in disease is unknown. This objective will demonstrate how variation in intrapersonal strain-level
diversity impacts bacterial physiology and BV progression. Second, this proposal will characterize the role of
single-cell transcriptomic heterogeneity in microbial interactions related to BV and responses to antimicrobials
through applying the new approach, bacterial single-cell RNA-seq, to in vitro vaginal communities and clinical
specimens (Objective 2). This innovative analysis will result in the identification of transcriptomic subpopulations
with altered traits, including pathogenesis and antimicrobial susceptibility, that can be targeted to promote vaginal
health. Overall, this proposed work will have broad implications in our understanding of the drivers of BV and
polymicrobial infections, suggesting novel approaches for the prevention and treatment of diseases.

Public health relevance
PROJECT NARRATIVE Despite extensive characterization, we struggle to understand and control the progression of human-associated microbial communities, including bacterial vaginosis (BV), a condition that is directly impactful to women’s health and the acquisition of sexually transmitted infections. This proposal investigates single-cell genomic and transcriptomic heterogeneity as two underexplored areas that impact the progression of BV. This intellectually and methodologically innovative research will transform our understanding of the development, treatment, and recurrence of BV and will provide broad-reaching insights into new strategies to prevent and treat polymicrobial infections.